Neuronal Ensemble Mechanisms of Behavior and Plasticity in a Cnidarian

Project Summary/Abstract
Deciphering how neuronal ensembles, groups of coactive neurons, control specific behaviors and
mental states is important for understanding behavioral disorders caused by mental or neurological
condition such as Parkinson’s, Alzheimer’s, epilepsy, schizophrenia, and autism spectrum disorders.
Knowledge about how neuronal ensembles lead to specific behaviors and mental states can help us
understand their pathophysiology and lead to better development of diagnostics and therapy for these
impairments. Specific behaviors and mental states are achieved by transforming the activity of multiple
neuronal ensembles into behavioral output. However, it is still unclear how neuronal ensembles interact
with each other in order to achieve specific behaviors and mental states, since this is a brain-wide
process. The goal of this proposal is to elucidate the neuronal ensemble mechanisms of feeding
behavior and neuronal plasticity, at a whole-body scale using the cnidarian Hydra vulgaris, a small and
transparent animal with a simple nervous system and a distinct set of complex behaviors. In Hydra,
methods to record and stimulate the activity of all neurons and muscle cells have been established.
Aim 1 will involve the dissection of functional circuits and neuronal ensembles for feeding. We will image
the entire neuronal activity during chemically-induced feeding and then stimulate specific neurons to
evoke the behavior. We will also have access to the Hydra connectome, the synaptic connectivity matrix
of all the neurons, and confirm it with laser stimulation to build a wiring diagram for feeding. After
characterizing the neural circuits for feeding, Aim 2 will characterize the mechanism of feeding
habituation of Hydra, a basic form of learning which exist in cnidarians. We will conduct imaging and
photostimulation experiments to identify neuronal types mediating habituation. We will further identify
the basis of neurotransmission required for the learning using endogenously expressed neuropeptides.
The proposed research program will provide a comprehensive understanding of a behavior and
generate a complete set of neuroscience tools to explore the role of ensembles in neuronal plasticity
and internal states that control behaviors. These findings could therefore impact mammalian
neuroscience and provide a basic science evolutionary perspective to better understand the neural
basis of behavior and plasticity. As ensembles are impaired in mouse models of epilepsy, Alzheimer’s,
Parkinson’s, schizophrenia, and autism, to better understand their basic biology could potentially impact
the study of the pathophysiology of many disease processes.

Public health relevance
Project Narrative Neuronal ensembles are groups of coactive neurons that play an essential role in perception and memory and are impaired in mouse models of epilepsy, Parkinson’s, Alzheimer’s, schizophrenia, and autism spectrum disorders. We do not know how ensembles are coordinated to generate behaviour, due to the lack of experimental tools to study populations of neurons at the whole-brain level. This proposal aims to broaden our understanding of behavioral control by studying the neuronal ensemble mechanisms and plasticity of a cnidarian, Hydra, where one can image and selectively manipulate the activity of all the neurons in its nervous system.